Training in Schizophrenia and Psychotic Disorders: From Animal Models to Patients

Project Summary
This application is for renewal of grant 5T32MH018870, “Training in Schizophrenia and Psychotic Disorders:
From Animal Models to Patients”, that has been funded since 1988. The goal is to train postdoctoral (MD,
MD/PhD, and PhD) fellows for careers as independent researchers. Achievement of our goal is measured by
how many fellows continue in a research-intensive trajectory whether supported by a K award or other sources
of funding. During an intensive three-year program, fellows learn to identify key research questions, formulate
hypotheses, and design and execute experiments that test those hypotheses. Other skills required for a fellow
to become an independent researcher include understanding the administration of a successful research
enterprise, effective collaboration and writing grants. Comprehensive training in the Responsible Conduct of
Research begins early in the fellowship. A fellow must maintain the highest standards of scientific integrity and
understand the ethical issues relevant to human and animal research.
The success of the training program is reflected in both the accomplishments of the trainees and in the
diversity of the fellows. In the past 15 years, 42 fellows have been selected to enter the training program; 33%
female, 10% minorities, 33% MDs, 29% MD/PhDs and 38% PhDs, with 29% from the Columbia Psychiatric
Residency program and 71% from outside. Over the past 10 years, due to our enhanced minority recruitment
efforts and the impact of the Levy Fellowship on our ability to recruit trainees, we have recruited 15% minorities
and 38% of non-white and/or non-European descent, and the fraction recruited from the Columbia residency has
climbed to 42%. Furthermore, our fraction of MD/PhDs has increased to 31% over the past 10 years. The
graduation rate of the fellowship is 97% over the last 15 years (31/32); the one fellow who did not graduate left
after 1 year of research on the translation of research findings into mental health policy and practice to pursue a
clinical administration position in the New York Office of Mental Health implementing his research, which we also
consider a success. Of these graduates, 94% have remained in research, with 70% in research-intensive
positions and 24% in research-related positions. Of the 31 fellows who have graduated the program in the last
15 years, 69% have been awarded K awards. Of those who graduated more than 5 years ago, 62% have received
R-level funding from the NIH, 72% have received major federal funding (NIH or Department of Defense), and
95% have received one or more research grants of some kind (including foundation support). Currently, there
are 8 fellows: 2 third-year, 2 second-year, and 4 in the first year of training; one fellow has been accepted to
begin in July 2019.

Public health relevance
PROJECT NARRATIVE This program trains MDs, MD/PhDs, and PhDs for careers as independent researchers in schizophrenia and psychotic disorders. An intensive three-year program of didactics and execution of research is described. Fellows learn to identify research questions, formulate hypotheses, design and execute experiments to test those hypotheses, understand effective collaboration with other researchers and the administrative organization of a successful research program, and write grants to obtain funding from federal agencies and private foundations.